COMPOUNDS MODIFYING GROWTH AND DIFFERENTIATION OF HUMAN ESOPHAGEAL CELLS

By using chemically defined serum-free LHC media, we have investigated the effects of selected compounds on growth and differentiation of human esophageal epithelial cells. The effects were evaluated on clonal growth rate (CGR), i.e., population doublings per day (PD/D), cross-linked envelope (CLE) formation, and the enzymatic activities of ornithine decarboxylase (ODC) and plasminogen activator (PA). In LHC media, the cells did not possess a stratified differentiation, but grew well. CGR was 0.9 +- 0.07 in LHC-8 media and 1.0 +- 0.08 in medium 199 containing 10% fetal calf serum. We found epidermal growth factor (EGF) was inhibitory to CGR, while it increased ODC activity of cells. Bovine pituitary extract alone increased both CGR and ODC activity. ACTH and beta-endorphin also stimulated CGR with an increased C-AMP level. These compounds did not affect PA activity and CLE formation. The effects of 12-0-tetradecanoyl phorbol-13-acetate (TPA) varied depending on media. TPA was inhibitory to CGR, but induced ODC and PA activities, and terminal squamous differentiation in LHC medium without EGF. Induction of ODC activity and terminal differentiation by TPA were not found in LHC media with EGF. W-7, an antagonist of calcium binding protein, calmodulin, was inhibitory to CGR (ID50: 8 x 10 to the negative sixth power M) and ODC activity. Fifty percent growth inhibitory dose of TPA was decreased more than 10-fold in the presence of 10 to the negative seventh power M W-7. W-7 blocked induction of ODC activity, and slightly enhanced the induction of terminal differentiation by TPA.